Cell Competition in Development and Homeostasis

A process of cell competition can remove cells that differ genetically from neighboring
cells in the same tissues. Cell competition helps to eliminate sporadic aneuploid cells
that have abnormal chromosome numbers. Aneuploidy contributes to almost all
carcinogenesis and is a hallmark of aging, contributing to cellular senescence. The
current project investigates the mechanisms by which genes that encode ribosomal
proteins, by virtue of their wide distribution in the genome and stoichiometric
requirement for ribosome biogenesis, are used as sensors for altered cellular
chromosome content, using fruitflies as a genetic model system. Importantly, cells with
single mutations in ribosomal protein genes can also be recognized and removed from
developing tissues by the process of cell competition with nearby normal cells, related
to the elimination of aneuploid cells. This project will further define the molecular
mechanisms of cell competition pathways by gain and loss of function genetics targeted
specifically to aneuploid cells within otherwise normal tissues, and characterize the
alterations in gene expression that result from cell competition on a single cell level.
The relationship of specific chromosome gains and losses to tumor formation will be
defined. The mechanisms whereby the p53 protein protects the genome from
progressive genome damage, and the route by which genomic changes accumulate in
the progression towards cancer, will be elucidated. These studies aim to define the
molecular basis for the cellular recognition and elimination of aneuploid cells in
developing tissues, its role in maintaining genome integrity at the tissue level by
selection against abnormal cells, and its role in tumor surveillance and the development
of cancers.

Public health relevance
Evidence is emerging that a process of cell competition helps eliminate abnormal cells with the potential to develop into cancers and cause aging. By identifying and characterizing the molecular processes involved, it will be possible to measure the extent of this process and develop approaches to reduce cancer incidence and promote healthy aging.